Non-invasive Electrical Stimulation as a Therapy for Diabetic Keratopathy

Project Summary: This project focuses on exploring the effectiveness of non-invasive transpalpebral electrical
stimulation (TpES) as a treatment for diabetic keratopathy (DK), a common complication in individuals with
diabetes. DK results from nerve damage in the eye, leading to symptoms such as dryness, pain, and potential
corneal injuries. Currently, the main treatment is a costly medication that can cause discomfort and requires
frequent applications, making it hard for many patients to tolerate.
The main objectives are to understand how TpES encourages the regeneration of corneal nerves and reduces
painful sensations caused by nerve damage. By looking at the molecular processes involved, we hope to
identify how this treatment not only helps the nerves grow back but also manages pain effectively.
Methods will include assessing the structural and functional changes in corneal nerves following TpES
application, as well as examining the underlying molecular mechanisms involved in nerve regeneration and
pain modulation. The study will utilize behavioral analyses, molecular biology, and single cell imaging to gain
insights into how TpES influences nerve recovery and reduces painful sensations.
Ultimately, this research aims to establish TpES as a low-cost, effective treatment option for patients suffering
from DK, enhancing their quality of life and addressing a significant unmet need in diabetic eye care. If
successful, this treatment could change how we approach care for individuals with diabetic eye issues.

Public health relevance
Project Narrative: This project aims to investigate the neuro-regenerative effects of non-invasive transpalpebral electrical stimulation (TpES) for treating diabetic keratopathy, a common complication in diabetes that leads to significant corneal damage, to develop a low-cost, take-home and effective treatment. We will evaluate the impact of TpES on corneal nerve regeneration and reepithelization in both type 1 and type 2 diabetes models and the molecular events, focusing on calcium-induced potassium channels and its relationship with axonal growth promoting transcription factors. We will also evaluate the action of TpES on neuropathic ocular pain and the mechanism of action aiming to alleviate discomfort from noxious stimuli while preserving normal sensory function necessary for tear secretion.